Evaluating extent and outcomes of isoniazid exposure during pregnancy among infants born to women living with HIV

Tuberculosis (TB) in pregnancy increases risk of adverse perinatal outcomes, including preeclampsia, preterm
birth, low birthweight, and neonatal death. Pregnant women living with HIV (WLHIV) in high burden settings are
at elevated risk for TB, despite high antiretroviral therapy (ART) uptake. Isoniazid (INH) as TB preventive therapy
(TPT) is routinely offered to pregnant WLHIV at high risk of TB in the US and globally. Safety studies of INH for
TB prevention in pregnancy show inconsistent results and call for more robust evaluations of perinatal outcomes
following prenatal INH use. To date, no studies have assessed perinatal and infant growth outcomes in the
context of quantified cumulative maternal and infant in-utero INH exposure. Further, limited safety data exist for
INH use in pregnant WLHIV on newer dolutegravir (DTG)-based ART regimens, which may interact differently
with INH. Acquiring safety data from programmatic INH initiation across gestational ages, including 1st trimester,
could inform prenatal INH policies for WLHIV on DTG-ART. We currently quantify DTG exposure via drug
measurements in breastmilk and hair in an ongoing cohort (n=480) of WLHIV on DTG-ART enrolled in pregnancy
and followed with their infants to 36 months to evaluate safety outcomes in Kenya—a setting where there is high
uptake of programmatic INH during antenatal care by WLHIV (PrIMA-DTG, P01HD107669 Project 1). PrIMA-
DTG built a maternal/infant specimen repository to assess other drug exposures, including INH. Among WLHIV
enrolled in PrIMA-DTG, 60% initiated INH during pregnancy, of whom 40% initiated in the 1st trimester and 53%
in the 2nd trimester. Using methods to measure HIV drug levels in hair that our team refined in maternal/infant
pairs, we will quantify INH exposure in WLHIV receiving INH for TPT in pregnancy and their infants using existing
hair samples from the well-characterized PrIMA-DTG cohort (Aim 1) and assess if extent of INH exposure is
associated with perinatal and infant outcomes (Aim 2). Our overall goal is to use objective measures to provide
comprehensive safety data on INH exposure for pregnant WLHIV on commonly used DTG-ART and their infants.
This will be the first large-scale study to directly quantify cumulative maternal INH exposure and fetal transfer in
the context of DTG-ART. By leveraging our expertise in perinatal ART safety and TB, high prenatal INH use
among WLHIV in Kenya, and an existing maternal/infant specimen repository designed for studies like the one
proposed, we are uniquely positioned to execute the proposed aims. This study is intentionally designed to
address existing gaps in the safety data of prenatal INH use among WLHIV on DTG-ART. Our findings will inform
TB prevention policies and clinical practice in the US and globally by providing INH safety data across gestational
ages with objective exposure measures.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) preventive therapy with isoniazid (INH) is recommended for pregnant women living with HIV (WLHIV) in high TB burden settings and for those at high risk of TB in the U.S.; however, safety data from studies involving older HIV treatments are inconsistent, with some showing increased risks of low birth weight, preterm delivery, pregnancy loss, and infant growth faltering. We will use biospecimens and rigorously collected perinatal outcome data from an existing, well-characterized cohort of pregnant WLHIV on dolutegravir (DTG)-based antiretroviral therapy—the current global first-line HIV treatment—to quantify cumulative maternal INH exposure and in-utero drug transfer at multiple gestational ages using advanced liquid chromatography-tandem mass spectrometry (LC-MS/MS) analysis of hair samples, and assess associations with adverse perinatal and infant growth outcomes through one year. This work will fill critical evidence gaps and inform clinical guidelines and policy decisions on the safety of prenatal INH use in both global and U.S. settings.